Role of Kidney Microvasculature-Secreted Factors in Neuropilin Signaling in Proximal Tubule During Diabetic Kidney Disease

Project Summary. Diabetic kidney disease is a complication affecting more than 36% of diabetic patients in the
United States. There is a medical need to minimize the impact of diabetic kidney disease since at later stages
the only options for survival are dialysis or kidney transplant. The goal of this application is to characterize a
molecular mechanism of cell-cell communication between kidney peritubular capillaries and proximal tubule. We
propose that early in diabetes, before the decline in renal function, the documented deterioration of the kidney
microvasculature interrupts the communication with proximal tubule via secreted factors, resulting in proximal
tubule damage and diabetic kidney disease. Our preliminary results have identified candidate surface receptors
in proximal tubule, neuropilins, that mediate cell signaling we found decreased in the Akita mouse model of type-
1 diabetes. Akita mice develop diabetes, but the progression of kidney disease is inconsistent and depends on
the genetic background. We will use Akita mice on 129Sv background (129Sv/Akita) since they develop kidney
disease. It is not known whether neuropilins mediate cell-cell communication between peritubular capillaries and
proximal tubule and whether this is decreased in diabetes. Our central hypothesis is: “Neuropilins maintain
proximal tubule epithelial phenotype by sensing secreted factors from peritubular capillaries, therefore
interruption of this cell-cell communication pathway in type-1 diabetic 129Sv/Akita mice contributes to kidney
damage”. In Specific Aim 1 we will determine whether decreased neuropilin signaling in proximal tubule
contributes to diabetic kidney disease in 129Sv/Akita mice. In Specific Aim 2 we will determine whether
decreased neuropilin-mediated cell-cell communication with peritubular endothelium impairs proximal tubule
epithelial phenotype and contributes to diabetic kidney disease in 129Sv/Akita mice. To complete this proposal,
we will utilize a combination of in vitro and in vivo approaches that include cutting edge techniques like intravital
multiphoton imaging, in vivo gene transduction, proteomics and single-cell transcriptomics. We expect to make
an impactful contribution towards better understanding the events that lead to diabetic kidney disease, providing
the foundations for future therapies. Cell-cell communication pathways like the one we propose have not been
considered as mechanism of diabetic kidney disease. Completing this proposal will cement this concept,
therefore providing the scientific framework for a competitive future R01 proposal.

Public health relevance
Diabetes is the leading cause of chronic kidney disease, putting a heavy burden in society despite decades of research and availability of treatments to control blood glucose. Better understanding of the cellular mechanisms occurring early in the diabetic kidney, before renal damage has occurred, will inform the development of effective treatments for diabetic kidney disease. The objective of this proposal is to address this need by studying cell-cell communication between kidney cells, which we believe is interrupted early in the diabetic kidney and results in renal damage.